UCSD Shiley-Marcos Alzheimer's Disease Research Center P30

Alzheimer’s disease and related dementias (ADRD) are a growing public health issue with tremendous cost
and unfathomable aggregate suffering. Unless the diseases can be effectively treated or prevented, increasing
prevalence in an aging population will escalate costs that the country will struggle to bear. With new
diagnostics and therapies emerging, there has never been a greater need or opportunity to pursue
groundbreaking ADRD research. This application for renewed funding of the UCSD Shiley-Marcos Alzheimer’s
Disease Research Center (ADRC) explicitly aligns with the National Alzheimer’s Planning Act (NAPA) and
builds on the Center’s 40-year legacy of dynamic research and engagement excellence. The Center’s
exceptionally rich academic and community environment, and its commitment to team-science and inclusion,
position it to work effectively as a member of the ADRC network toward achievement of national priorities. The
Center’s theme and foci are to explore markers, mechanisms, and models to better understand the
clinical and pathologic features and heterogeneity of ADRD, and to apply this new knowledge for a
diverse, aging population. In particular, we aspire to bring world-class translational neurosciences to the study
of heterogeneity and diversity in ADRD. We will develop and apply new markers and models, tailor community-
engagement approaches to foster greater participation of diverse populations, and advance culturally sensitive
practices in ADRD science relevant to Latinos – a growing demographic group in our region and in the U.S.
This work includes innovative human cell model work fostered by its iPSC Core and state-of-the-art
approaches in diversity science of its Latino Core that influences and spans Center activities. Integration
across all Cores is bolstered by strong institutional commitment to the Center’s continued success and to
cutting-edge, disruptive, transdisciplinary team-science. We propose the following overarching aims that reflect
and unify our activities in research, education, engagement, and sharing and synergizing with the ADRC
network. The Center will: 1) Support integrated, interactive Cores that conduct innovative, interdisciplinary,
inclusive team-science research to benefit the diversity of individuals affected by ADRD; 2) Educate, train, and
improve preparedness of a more diverse workforce; 3) Serve as a hub for scientific and community exchange
and support, applying synergistic Core efforts to engage, inform, and empower patient, caregiver, and research
communities; and, 4) Engage deeply in collaborative research across ADRCs and with other NIH-supported
initiatives, with special emphasis on applying Center strengths to complement those within the ADRC network
and extend its impact.

Public health relevance
OVERALL - NARRATIVE Development of more effective approaches to prevention, diagnosis, care, and therapy of Alzheimer’s disease and related dementias (ADRD) is critically needed in the face of an aging and increasingly diverse population. Advances in the field require targeted, more inclusive team-based research that addresses the needs of understudied populations, as well as complexities related to the heterogeneity of ADRD. The Shiley-Marcos Alzheimer’s Disease Research Center coordinates activities to foster this science, engage the research and broader communities, and educate an emerging and more diverse cadre of brilliant, creative investigators.